Refer 2 Quit: Proactive Promotion of Tobacco Use Treatment for Underserved Household Members Who Smoke through Pediatric Primary Care

Project Summary/Abstract
Racial and ethnic minority groups and those from low socioeconomic groups suffer disproportionately from the
effects of tobacco marketing, have less access to evidence-based treatments for tobacco use, and report
needing more support for cessation efforts. Pediatricians are uniquely positioned to help medically
underserved families to address smoking and protect children from secondhand smoke (SHS) exposure, but
appropriate treatments are rarely delivered to parents who smoke. Emerging clinical decision support (CDS)
systems within electronic health records (EHRs), including those developed by this team, help pediatricians
screen for SHS exposure, motivate parent treatment engagement, and prescribe and/or connect caregivers to
tobacco interventions. Office-based approaches, however, focus only on caregivers attending clinic visits with
their children, failing to reach additional household members who smoke, leaving many adults without access
to evidence-based treatments and children continually exposed to detrimental effects of SHS. Thus, a major
barrier to protecting children from SHS exposure and extending tobacco use treatment to underserved adults
who smoke is identifying an efficient and scalable method to engage all household members who smoke, not
just parents who present to the pediatric clinic with the child. This proposal uses an innovative, multi-
disciplinary research approach incorporating both population health and clinical informatics implementation
strategies to overcome this barrier and systematically expand the reach of tobacco use treatment through
pediatric healthcare settings. EHR-based informatics tools can efficiently identify additional household
members who smoke and proactively offer tobacco treatment. Using a rigorous, 2-arm pragmatic randomized
control trial within a large pediatric network comprising practices with high rates of Medicaid-insured children,
we will compare a novel intervention using population health and clinical informatics implementation
strategies vs. usual care to increase the reach, effectiveness, and health equity of tobacco use treatments.
We will use a Type 2 hybrid effectiveness-implementation design, measuring the clinical intervention's impact
on priority outcomes and testing an implementation strategy. The specific aims are: Aim 1) To compare the
reach of Refer2Quit - a proactive, population health and clinical informatics implementation intervention on
tobacco use treatment engagement for household members who smoke vs. usual care; Aim 2) To compare the
effectiveness of the Refer2Quit intervention for increasing quit rates among household members who smoke
vs. usual care; and Aim 3) To study household member and pediatric patient characteristics that are
associated with reach and effectiveness of Refer2Quit. This addresses a significant practice gap in the
utilization of evidence-based treatments for tobacco, particularly for underserved populations. Leveraging the
pediatric setting can increase access and use of evidence-based tobacco treatments. This proposal will yield a
scalable strategy to address the impacts of tobacco use within under-served communities.

Public health relevance
Project Narrative Racial and ethnic minority groups and those from low socioeconomic groups suffer disproportionately from the effects of tobacco marketing, have less access to evidence-based treatments for tobacco use, and report needing more support for cessation efforts. Pediatricians are uniquely positioned to help medically underserved families to address smoking and protect children from secondhand smoke (SHS) exposure, but a major barrier to protecting children from SHS exposure and extending tobacco use treatment to underserved adults who smoke is identifying an effective and scalable method to engage all household members who smoke, not just parents who present to the pediatric clinic with the child. To address this barrier, we will conduct a pragmatic trial through a large, urban pediatric network to evaluate a novel, proactive intervention that uses population health and clinical informatics implementation strategies to increase the reach, effectiveness, and health equity of tobacco use treatments for underserved families.